Trophic interactions directing proper kidney development

Abstract
Vascular and neuronal networks permeate tissues throughout the body, perfusing them with oxygen and
nutrients and enabling crosstalk with the central nervous system. A tight association between nerves and vessels
is vital for reciprocal communication that maintains homeostasis. During development and regeneration, nerves
and vessels grow and expand together, and, in many cases, vessels guide nerves to their targets. Recent
investigations have uncovered novel roles for nerves in modulating developmental processes and regeneration
in several organs. An ever-expanding repertoire of additional nerve functions is continuously being uncovered.
However, there is a significant gap in our understanding of the neuro-vascular interplay within the developing
kidney and whether nerves play active roles in kidney development. Therefore, we set out to begin addressing
these deficiencies. We found nerve fibers first innervate the kidney at E13.5 through a strict association with
vascular smooth muscle cells (VSMCs) of the maturing arteries. This association expands the nerve network
alongside the arterial tree throughout development. Disrupting the arterial pattern also disrupts the nerve
network, highlighting a reliance on the vasculature for guidance. Sympathetic and sensory neurons both
innervate the kidney and associate with developing and mature nephrons. Strikingly, genetic ablation of kidney
innervation leads to a deficit in postnatal nephron numbers. Based on our novel findings, we hypothesize that
VSMCs guide kidney innervation to direct proper nephron differentiation. To test this, we will leverage our
expertise in imaging and transcriptomics to interrogate phenotypes, identify pathways of cellular crosstalk, and
gain mechanistic insights. In our first Aim, we will genetically ablate VSMCs to parse apart the reliance of nerves
on VSMCs for initial kidney innervation versus continued guidance to developmental targets. Kidney VSMCs will
be isolated at embryonic and postnatal stages for single-cell (sc)RNA-seq to determine the signaling pathway(s)
required for neuro-vascular associations. By employing Translating Ribosome Affinity Purification (TRAP) to
isolate transcripts actively translated in kidney axons, we will identify neuronal receptors critical for VSMC-nerve
crosstalk. In our second Aim, we will genetically ablate sympathetic and sensory neurons independently or in
combination to determine which neurons modulate nephrogenesis. We will employ light-sheet and confocal
imaging, along with quantitative metrics, to interrogate nephron differentiation in our models and track
phenotypes across development. To garner mechanistic insights into cellular programs that are disrupted by the
absence of innervation, we will perform scRNA-seq on denervated kidneys, comparing the results to our
phenotypic analyses to help identify the pathways involved. Additionally, we will interrogate the axonal
transcriptome to determine signaling factors mediating nerve-kidney crosstalk. These studies will generate novel
resources and insights into how nerves rely on the vasculature for proper guidance enabling them to modulate
nephrogenesis. Our findings will support and enhance regenerative efforts and tissue replacement strategies.

Public health relevance
Project Narrative Kidney organogenesis requires extensive cellular crosstalk to enable proper development and the establishment of physiological function. We have uncovered novel roles for renal vascular and neuronal networks in supporting organogenesis and our goal is to identify the molecular programs mediating crosstalk between these networks and with the developing kidney. Our findings will support efforts to regenerate and engineer vascularized, innervated, and functionally mature kidney tissues.